MYOCARDIAL ADAPTATIONS TO ADVANCE AGE AND EXERCISE

In advanced age (AGE), the stiffness of the heart increases, contraction duration is prolonged, myocardial relaxation is impaired, and the ability of the heart to regulate cellular Ca2+ load is impaired. AGE- dependent alterations in sarcolemmal (SL) and sarcoplasmic reticular (SR) Ca2+ handling processes are thought to contribute to these undesirable changes. Endurance exercise training (TR) ameliorates many of these AGE- related functional changes in the heart. While TR has shown to improve SR function in the aged heart, little is known about the effects of TR on the SL Ca2+ regulatory processes in AGE. Processes that affect transarcolemmal Ca2+ movement are very important in the regulation of cardiocyte Ca2+ balance and cardiac contractile force development. Any perturbation in the dynamic equilibrium that exists between the cellular Ca2+ influx and efflux pathways would be expected to affect the ability of the myocardium to regulate cellular Ca2+ content, SR Ca2+ load, and ultimately cardiocyte contractile function. The objectives of this proposal are to determine the effects of AGE and TR+AGE on key elements of cardiocyte Ca2+ regulation in the F1 hybrid rat model. Fluorescence microscopy, rapid solution switching, and whole cell electrophysiologic techniques will be employed to determine whether or now AGE and TR+AGE affect SL NaCa exchange, the primary pathway of Ca2+ efflux from the cardiocyte. These techniques will also be exploited to determine how AGE and TR+AGE affect the relative contributions of the SR, NaCa exchange, the sarcolemmal Ca2+ ATPase (pump), and the mitochondria to cytosolic [Ca2+] regulation in intact cardiocytes. In order to gain an appreciation of how integrated cellular Ca2+ regulation is affected by AGE and TR+AGE, LV contractile function of Langendorf perfused hearts and releasable SR Ca2+ load in paced cardiocytes will be assessed under experimental conditions designed to perturb cellular Ca2+ influx and/or efflux. Collectively, the information resulting from the proposed studies should provide insights into the cellular basis of the adverse affect of AGE and the positive effects of TR on cellular Ca2+ homeostasis in the heart. A large portion of the US population will reach advanced age and be at risk of age-dependent reductions in cardiac function in the next 25 y. An understanding of the cellular processes that underlie TR-induced functional adaptations in the aged heart may prove useful in the development of strategies to prevent and/or reverse myocardial senescence, particularly in a setting where parallel pharmacological intervention is being used. The likelihood of the latter increases in advanced age.